An Implementation-Effectiveness Study of an Evidence-Based Intervention to Improve Head Impact Safety in Youth Football

PROJECT SUMMARY
Repetitive head impacts in contact sports are a significant public health concern due to their potential association
with short- and long-term neurological deficits. There is debate amongst researchers as to the amount of
exposure that may lead to neurocognitive changes; some researchers have demonstrated that these alterations
could occur over the span of one season. Youth football players represent 70% of all athletes participating in the
sport and experience over half of their head impacts during practice - an environment amendable to intervention.
A current study (1K25HD101686-01A1) will develop an evidence-based intervention aimed to reduce head
impact exposure in practices, using a community-engaged approach. This proposal enhances this parent study
by incorporating clinical outcome assessments and engaging football athletes in the evaluation of the intervention
program. The objective of this implementation-effectiveness study is to evaluate the effectiveness of the
intervention program on reducing exposure in practices and its effect on mitigating changes in clinical
outcomes, while monitoring the implementation process. In Aim 1, measures of neurocognition, postural
control, and vestibular/ocular motor symptoms will be evaluated from athletes participating on control and
intervention youth football teams as well as non-contact sports teams at pre- and post-season time points.
Biomechanical data informing the frequency and severity of hits during the season will be measured using a
custom instrumented mouthpiece. The effectiveness of the intervention at reducing head impact exposure and
mitigating changes in clinical outcomes will be evaluated. In Aim 2, the feasibility and potential utility of the
implementation strategy of the intervention program will be assessed to inform intervention program outcomes.
Former youth football players participating at the high school and collegiate level will be engaged to evaluate the
feasibility and acceptability of the intervention program. The results of this study will provide important pilot data
on the effect of reducing exposure on clinical outcomes, while informing how the intervention program works and
providing valuable insight into future large-scale testing of the intervention. The predoctoral Candidate will
achieve the study aims through cross-disciplinary mentorship in injury biomechanics, public health,
implementation science, neuropsychology, and sports medicine. This fellowship opportunity will also provide
robust didactic training and experiential learning in traumatic brain injury, methods of biomechanical data
collection and implementation science, biostatistics, clinical trials design, neurocognitive test administration and
interpretation, and professional development. The research and training plan of this Predoctoral Fellowship will
position the Candidate for success as a productive independent research scientist with a skillset to combine
injury biomechanics and public health to assess injury prevention strategies.

Public health relevance
PROJECT NARRATIVE Exposure to repetitive head impacts in contact sports such as football is a rising public health concern due to the connection with brain disease later in life and changes in the brain after a single season. This F31 Independent Predoctoral Fellowship Award will investigate the effectiveness of a novel evidence-based intervention program to reduce head impact exposure and negative clinical outcomes in youth football, while assessing the acceptability and feasibility of the intervention and utility of the strategy used to implement the intervention program. Formal training and experiential learning will prepare the applicant to become a productive and independent research scientist with cross-disciplinary skills in injury biomechanics and public health.